Multi-level Evaluation of Racial/ethnic Disparities in Liver Disease Outcomes

ABSTRACT
Cirrhosis – the end-stage result of chronic liver disease – is a condition with high morbidity and
mortality that is becoming increasingly common. Nearly half of all patients with cirrhosis develop
hepatic decompensation including hepatocellular cancer (HCC), with frequent hospitalization
within 5 years of cirrhosis diagnosis. Several studies show that these cirrhosis complications
disproportionately affect racial/ethnic minorities and persons of low socioeconomic status (SES).
But fundamental questions remain unanswered given that only few studies investigated the
mechanisms that underlie these disparities. The research proposed here aims to provide
actionable information on what to target to reduce cirrhosis prognosis disparities. We will
conduct a comprehensive evaluation of multilevel factors hypothesized to play important roles in
causing racial/ethnic and SES disparities in three key measures of cirrhosis prognosis: a)
hepatic decompensation, including HCC, b) liver-related hospitalization, and c) overall survival.
We propose a large, multicenter, racially and socio-economically diverse cohort study of
cirrhosis patients enrolled from four healthcare systems; the project will combine information
from existing clinical databases, genomic data, and geospatial analyses with patient- and
clinician- surveys to provide unparalleled information about the role of individual, interpersonal,
and community-level factors in the racial/ethnic and SES disparities in cirrhosis prognosis.
The proposed cohort includes representative groups from all racial/ethnic (blacks, Hispanics,
Asian-Pacific Islanders) and SES groups. It also spans the full spectrum of disease severity
(from compensated to advanced decompensated disease), rather than focusing on a few
groups. We will uncover the relative contributions of established (hepatitis C virus, hepatitis B
virus) and emerging (obesity, diabetes) etiological risk factors as well as risk behaviors (alcohol
use) to cirrhosis prognosis disparities. We will also characterize pathways that contribute to
cirrhosis disparities among the high order determinants at the individual (e.g., medical mistrust),
interpersonal (e.g., bias), and community (e.g., access to transportation) levels either directly or
by affecting etiological or behavioral risk factors. Identification of these root cause mechanisms
will identify actionable targets for intervention and policy change. We will also examine a set of
genetic single nucleotide polymorphisms using stored sera in a subset of the cohort to
understand the role of genetic differences, if any, in explaining racial/ethnic disparities.

Public health relevance
8. PROJECT NARRATIVE Cirrhosis–the end-stage result of chronic liver disease–is an increasingly common condition that results in significant morbidity and frequent hospitalization, all disproportionately affecting racial/ethnic minorities and socioeconomically disadvantaged patients. This project represents the first necessary step in developing interventions to reduce these disparities and improve survival in racial/ethnic minority and socioeconomically disadvantaged populations. We will follow a large group of patients with cirrhosis to identify factors that explain these health disparities, with a special focus on reasons that can be changed with prevention and treatment.